Efficacy and mechanisms of exercise-enhanced fear extinction

ABSTRACT
The goal of the current project is to establish the efficacy and mechanisms of exercise-enhanced fear
extinction retrieval and generalization in posttraumatic stress disorder (PTSD). Exposure therapy is the gold
standard treatment for PTSD, yet is only associated with remission rates of ~55% and in clear need of
improvement. Exposure therapy is hypothesized to work through mechanisms of fear extinction learning, and
as such, laboratory-based fear extinction paradigms are widely used as models of exposure therapy. Recent
data demonstrates that moderate-intensity aerobic exercise, delivered specifically during or after fear extinction
learning, can boost the consolidation of fear extinction learning. Consistent with emerging models of exercise’s
pro-extinction effect, our pilot data among women with PTSD found that moderate intensity aerobic exercise
delivered after fear extinction learning leads to a reduction in subsequent fear responding 24hrs later, an effect
that was mediated by exercise-induced increases in peripheral BDNF. Our pilot data using multivariate pattern
analyses (MVPA) also identified divided neurocircuitry organization of fear vs safety memories, and that this
divided neural organization was altered in PTSD. Building on our pilot data, the current project would 1)
compare the impact of different intensities of exercise delivered following fear extinction learning on multimodal
measures of fear extinction retrieval and generalization, 2) identify the impact of exercise on MVPA
representations of fear vs safety memories, and 3) demonstrate that spontaneous reactivations of extinction
encodings in the acute consolidation window operate as candidate mechanisms by which exercise enhances
extinction retrieval and generalization. Using a 3-day fear conditioning, fear extinction, and fear extinction
retrieval and recognition task during fMRI, 200 adults with PTSD would be randomly assigned to either resting
control or 30min of either light, moderate, or high intensity exercise. Testing dose-response relationships
between exercise intensity and fear extinction will inform translation of this research to clinical settings. A one
week-follow-up extinction retrieval test would investigate the impact of exercise on longer-term retention. This
project would provide a critical evaluation of the impact of aerobic exercise on consolidation and recall of
extinction learning in PTSD samples, thereby providing a strong foundation to translate this research to clinical
care and enhance clinical outcomes for PTSD. The project would also provide general knowledge regarding
dose-response relationships and neural mechanisms that support enhanced extinction, thereby informing
development of additional novel treatments.

Public health relevance
Project Narrative The goal of the current project is to define the impact of multiple doses of exercise on the consolidation and recall of fear extinction learning and identify neurobehavioral learning mechanisms mediating enhanced extinction among individuals with PTSD. This research has the potential to inform the general mechanisms of extinction learning, the specific mechanisms of therapeutic learning in PTSD, and thereby enable development of more efficacious treatments for PTSD and other fear-related disorders.